Novel Translational Control Mechanisms in Host Range Restriction of Poxvirus

Project Summary/Abstract
The recent global emergence of mpox virus (MPXV) from unidentified animal reservoirs underscores the
significant public health threat posed by orthopoxviruses (OPXVs). This event highlights critical knowledge gaps
in understanding poxvirus host tropism, complicating efforts to predict, monitor, and prevent OPXV outbreaks.
Over the past two decades, our research has focused on elucidating the molecular determinants of poxvirus host
specificity, leading to the discovery of two interferon-stimulated genes, SAMD9 and SAMD9L (collectively
SAMD9/9L), which serve as key host restriction factors against poxvirus infections. SAMD9/9L have been under
positive selection across mammals, particularly in rodents, which are primary OPXV reservoirs. Species-specific
differences in SAMD9/9L act as barriers to cross-species poxvirus infection, while all OPXVs encode at least
one of three host-range factors (K1, C7, CP77) that inhibit SAMD9/9L and promote viral spread.
Our previous studies revealed SAMD9 as a poxvirus-activatable tRNA anticodon nuclease that selectively
depletes tRNAPhe, leading to ribosomal stalling and a proteotoxic stress response. We identified the tRNase
domain in SAMD9/9L and found that its activity underlies the known cellular functions of SAMD9/9L, including
the inhibitions of poxvirus replication, cellular protein synthesis, and cellular proliferation. Preliminary data
indicate that SAMD9/9L constitute a family of tRNases with distinct tRNA specificities, cleaving multiple tRNAs,
generating tRNA fragments, and inducing ribotoxic stress responses (RSR). Poxviruses counter these activities
through the C7 family of proteins, which specifically target SAMD9/9L's tRNA-binding and catalytic sites, driving
SAMD9/9L evolution in response.
This renewal proposal builds on our initial discovery to elucidate the novel molecular mechanisms by which
SAMD9/9L restrict viral replication and the viral strategies that counteract these defenses. In Aim 1, we will define
the tRNA specificity of SAMD9/9L, assess the impact of tRNA cleavage and fragmentation on poxvirus
replication, and characterize the downstream signaling pathway activated by ribosomal stalling. Aim 2 focuses
on defining how SAMD9 is activated by poxvirus infection, hypothesizing that viral uncoating releases specific
pathogen-associated molecular patterns (PAMPs) that activate SAMD9. Aim 3 will investigate the molecular
“arms race” between SAMD9/9L tRNase and poxvirus inhibitors, to understand how these viral proteins inhibit
SAMD9/9L function and shed light on the co-evolutionary dynamics between host restriction factors and viral
inhibitors.
This research will provide fundamental insights into SAMD9/9L-mediated antiviral mechanisms and poxvirus
evasion strategies, establishing a foundation for novel therapeutic approaches to combat poxvirus infections.
Additionally, it will enhance our understanding of pattern recognition mechanisms in eukaryotes and reveal
translational control mechanisms that link tRNA modification, cleavage, and cellular stress responses.

Public health relevance
Project Narrative Poxviruses include both emerging pathogens of significant public health concern and promising vectors for vaccine development. This project aims to reveal how specific intracellular immune sensors detect poxvirus infection and initiate an effective antiviral response through a novel translational control mechanism. Investigating the mechanisms that determine poxvirus host range will provide essential insights for developing antiviral therapies and optimizing poxvirus-based vaccines.